Unusual mechanisms of metal regulation in bacteria: from single molecules to single cells to cell communities

Defining how cells regulate the uptake and efflux of transition metals such as Zn is a key component in
elucidating cellular mechanisms of metal homeostasis. Bacterial model systems provide paradigms for
understanding regulation mechanisms. In E. coli, the Zn2+-responsive metalloregulator ZntR senses Zn excess
and activates Zn efflux systems (e.g., ZntA), while Zur senses Zn sufficiency and represses Zn uptake systems
(e.g., ZnuABC), to keep this essential metal at appropriate physiological levels in the cell. Past research has
provided significant insights into the structure, function, and mechanism of the protein players in regulating
cellular metal concentrations, including metalloregulators, and metal uptake/efflux transporters, etc. Yet, many
mechanistic pathways are still poorly understood, especially regarding spatially and temporally coordinated
interactions among proteins and/or DNA that can reside at different locations in the cell. The long-term goal here
is to understand how metal regulation in the cell can be manipulated for preventive and therapeutic purposes.
Toward this goal, the PI has established an internationally recognized and unique research program that applies
and develops advanced single-molecule/single-cell imaging approaches to interrogate and understand the
mechanisms of bacterial metal regulation both in vitro and in live cells, which are further enhanced by bulk
biochemical/biophysical and protein/genetic engineering approaches and by established collaborations with
biologists and engineers. The research has led to the discoveries of first-of-their-kind mechanisms of metal-
responsive transcriptional regulation and metal efflux. The objective of this renewal is to advance the study and
understanding of bacterial metal regulation from single molecules and single cells toward cell communities,
comprising three aims that focus on Zn regulation in E. coli: (1) define a “through-DNA” mechanism for Zn uptake-
vs-efflux regulation; (2) define the mechanism of ZnuABC for Zn uptake in the cell; and (3) dissect cell-cell
interactions in Zn homeostasis within bacterial communities. The research is significant because it will provide
novel mechanistic insights into: how metalloregulators can act on each other on DNA, beyond the present
paradigm of “set-point” mechanism; the spatiotemporal coordination of multicomponent Zn transporters for Zn
uptake; and the cell-cell interactions in Zn homeostasis within a bottom-up cell community; and because these
insights will deepen our understanding of cell biology of metals in general, including related processes in human
cells, thus providing fundamental knowledge for identifying causes or developing preventions of diseases that
involve similar regulation processes or for devising strategies to impair bacterial Zn homeostasis for antimicrobial
treatments. The research is innovative because it generates novel mechanistic concepts in metal regulation,
uptake/efflux, and emergent behaviors in microbial communities and because it applies novel single-
molecule/cell imaging methods as well as microfluidic and optogenetic manipulations.

Public health relevance
The proposed research is relevant to public health because the mechanisms identified will lead to the development of (bio)chemical strategies to manipulate Zn regulation in Gram-negative bacteria, which are related to many human pathogens. These strategies can be used to effect limitation of the essential micronutrient Zn, increase the toxicity of excess Zn, and thus restrict the growth of invading pathogens. Thus, the proposed research is relevant to the part of NIGMS's mission that pertains to laying the foundation for disease treatment and prevention.